MIDDLE EAR EFFUSION LEVELS OF CEFPODOXIME AFTER ORAL SUSPENSION ADMINISTRATION

The purpose of this study is to determine the penetration of cefpodoxime into middle ear effusion of pediatric patients with acute otitis media following administration of Vantin Oral Suspension as 5 mg/kg (200 mg maximum) twice daily.